The Mutagenic Effects of APOBEC3A and APOBEC3B in Urothelial Carcinoma

PROJECT SUMMARY & ABSTRACT
Abstract
As the most common malignancy of the urinary tract among men and women, bladder cancer is estimated to
surpass 80,000 new cases and 17,000 deaths is 2023. Accounting for most bladder cancers cases, urothelial
carcinoma has a dismal survival rate of approximately 5% in the metastatic setting. APOBEC3A (A3A) and
APOBEC3B (A3B) are members of a family of cytidine deaminase enzymes that catalyze the removal of an
amino group from cytosine nucleotides generating a uracil in its place that serve as a source of mutations. A3A
and A3B enzymes are commonly overexpressed in numerous cancer types, including urothelial carcinoma,
with the APOBEC mutation signature seen in most cases of this cancer type. Due to their mutagenic activity,
A3A and A3B have been implicated in altering the genomic landscape of urothelial carcinoma tumors over
time. These alterations have the potential to augment tumor cell clonality that can lead to an enrichment of
cells that are refractory to treatment and drive disease progression. Currently, it is unclear if both A3A and A3B
drive APOBEC-induced mutagenesis, or if one enzyme plays a larger mutagenic role than the other. This
proposal seeks the address the hypothesis that A3A and A3B enzymes differ in mutagenic activity leading to
differences in promotion of intratumoral heterogeneity and response to anti-PD-1 immune checkpoint blockade
inhibition. To address this hypothesis, two mouse bladder cancer cell lines entitled BBN963 and BBN976, that
are representative of human muscle invasive bladder cancer, will be developed to express either HA-epitope
tagged A3A or A3B, in a doxycycline inducible manner. Utilization of this model will allow for a direct
comparison of A3A and A3B induced mutagenic activity, tumor cell clonality diversification, and modulation of
response to treatment. Experiments detailed in Aim 1 will elucidate the driver of the APOBEC mutational
signatures in urothelial carcinoma using in-vitro assays to analyze the predicted target sequences of
APOBEC3 enzymes. Subsequently, Aim 2 will use DNA barcoding technology to compare the promotion of
intratumoral heterogeneity by A3A and A3B. Lastly, Aim 3 will determine the influence of A3A and A3B on
treatment response to anti-PD-1 therapy and the role these enzymes play in altering the tumor-immune
microenvironment utilizing an in-vivo approach. Completion of the work outlined in these aims will result in the
identification of the driver of APOBEC3 mutagenesis in urothelial carcinoma and highlight a potential target for
inhibition for combination therapy with immune checkpoint blockade in patients with elevated APOBEC3
mutagenic activity.

Public health relevance
PROJECT NARRATIVE APOBEC3 enzymes play a crucial role in several biological events in relation to innate and adaptive immune responses. The upregulation of APOBEC3A and APOBEC3B in urothelial carcinoma warrants further investigation and a direct comparison to determine the source of APOBEC3 induced somatic mutations in this cancer type. The studies outlined in this proposal will identify the source of APOBEC3 induced mutagenesis in urothelial carcinoma.